The Physiology and Biochemistry of Sepsis-induced Vasoplegia

Project Summary/Abstract
Sepsis is a complex, heterogeneous, global inflammatory response to an infection that precipitates critical
hypotension, is beset with high mortality, and constitutes a clinical emergency. Large blood vessels
(macrovessels) become atonic and fluid-permeable, while small vessels (microvascular beds) do not perfuse,
causing shock and hypoxic organ damage, a condition termed vasoplegia. Dr. Wise endeavors to become an
independently funded, collaborative surgeon-scientist by characterizing physiologic injury and defining cellular
processes that occur during the vasoplegia precipitated by sepsis. While elimination of the infectious pathogen
is most critical to survival, mitigating vasoplegic physiology prevents morbidity to vital end organs such as the
lung. Examining the problem of vasoplegia from the lens of the vascular system necessarily requires career
development in three key areas, identified to optimally address the research question: cell biology and multi-
omics, use of intravital surveillance techniques (microscopy), and facility with large animal models to best
recapitulate human physiology in sepsis. This project is well-positioned to succeed due to a complementary
mentorship and advisory team led by Dr. Greg Beilman (University of Minnesota), strong institutional support,
and a focused career development plan inclusive of germane coursework, didactics, seminars and meetings.
Vasoplegia will be studied using a newly-piloted porcine “fecal clot” (with ischemia-reperfusion injury)
model of surgically-induced sepsis. In the first Aim, fecal clot sepsis or “sham” sepsis will be induced, followed
by surgical harvest of mesenteric and saphenous arteries and veins after 24 hours. Cut rings from these
vessels will be suspended in a muscle bath to determine relative severity of injury of smooth muscle cells,
endothelial cells and extracellular matrix. Permeability will be assessed via immunohistochemical staining for
glycocalyx. Regulation of the endoplasmic reticulum stress response and P38 MAP Kinase activation by
putative endogenous inhibitor Niban will be studied, to assess the role of “off-signaling” in propagating septic
inflammation. In the second Aim, lung microvasculature will be imaged using intravital orthogonal polarized
spectral video-microscopy, to quantify the loss of perfused vessels and blood flow induced by fecal clot sepsis.
After synthesis of macrovascular and microvascular injury patterns of vasoplegia from the first two Aims, a pilot
mitigation strategy will be tested in the third Aim. Intravenous “NiPp,” a rationally designed cell-permeant
phospho-mimetic of Niban developed in the laboratory of Colleen Brophy (co-mentor), will be administered to
septic pigs, to decrease harmful “feed-forward” activation of injury-induced pro-inflammatory pathways leading
to vasoplegia. The primary outcome will be improvement in a validated clinical porcine sepsis score. All pigs
will have systemic vascular tissue extensively bio-banked upon euthanasia. The robust animal model, data to
be collected, and the learned research techniques will collectively predicate a dynamic research program, with
potential for translating our findings to ultimately improve survival from sepsis, a major unmet clinical need.

Public health relevance
Project Narrative The clinical sepsis syndrome occurs due to an overwhelming inflammatory response to an infection, and requires aggressive treatment. Sepsis is beset with very high mortality due to vasoplegia, a physiologic condition in which blood vessels do not work and fail to perfuse vital organs such as the lung. Using a robust porcine model of fecal peritonitis (fecal clot with ischemia-reperfusion injury) to recapitulate human disease, the proposed research will quantify physiologic impairment in vascular smooth muscle and endothelial cells, and explore concomitant dysregulation of “off-signaling” of harmful intracellular events as a putative mechanism.